Modified saRNA Encoded BiTEs for Lung Cancer

PROJECT SUMMARY/ABSTRACT
This proposal describes an innovative approach to treat lung cancer, the leading cause of cancer deaths in
the U.S., with a novel self-amplifying ribonucleic acid (saRNA) technology encoding for a bispecific T cell
engager (BiTE) antibody. Catalytic RNA technologies, such as saRNA offer substantial promise but opportunities
remain for performance optimization. saRNA encodes a virally derived RNA-dependent RNA polymerase (RdRp)
on the same RNA strand as the sequence for the desired protein cargo(s). After being translated, this RdRp
produces more copies of the RNA template, leading to amplification of the delivered construct with resulting
increased amounts and duration of the protein. Unfortunately, saRNA evokes a substantial innate immune
response leading to saRNA degradation, decreased transfection capability, and adverse in vivo side effects.
Although incorporation of modified nucleoside triphosphates (modNTPs) such as N1mΨU in mRNA yields a
clinically functional construct, multiple attempts to use N1mΨU in saRNA have been unsuccessful. These results
led to the conclusion that modNTPs are incompatible with saRNA. Contrary to these reports, we discovered
that other modNTPs at 100% substitution in saRNA reduce the innate immune response and confer
enhanced protein expression potency and duration. Using a functional protein expression screening assay,
we identified modNTPs including 5-methylcytidine (5mC), that are transcriptionally and translationally active.
5mC saRNA significantly enhances protein expression in multiple immortalized and primary human cell lines. A
single intramuscular injection of 5mC saRNA, encoding for luciferase, results in 30+ day protein expression.
Further, the type I interferon response is less in transfected primary human PBMCs in vitro and after
intramuscular administration in vivo compared to wild-type saRNA. We hypothesize that a 5mC modified
saRNA, encoding for a BITE, will afford a functional antibody that targets tumors and engages T cells
for killing, prolongs in vivo BiTE pharmacokinetics, and extends survival compared to a N1mΨU mRNA
or unmodified saRNA encoding a BITE or a conventional BiTE protein therapeutic in both patient-derived
xenograft (PDX) and immune competent murine models. Importantly, preliminary data support the proposed
studies, well-characterized materials and rigorous experimental designs are established, and essential cross-
disciplinary collaborations and expertise are in place to address this hypothesis. The specific aims of this five-
year proposal are as follows. Aim 1 designs 5mC modified saRNA constructs encoding BiTE antibodies and
evaluates protein expression performance in vitro. Aim 2 assess the in vitro/ in vivo bioavailability and resulting
in vitro bioactivity of the BiTE antibody translated from the 5mC modified saRNA constructs. Aim 3 determines
the maximum tolerated dose, pharmacokinetics, toxicity, and in vivo efficacy of 5mC modified saRNA, encoding
a BiTE antibody, against lung carcinomas. Furthermore, we will establish a unique saRNA treatment strategy
which will be broadly applicable to the sustained delivery of other therapeutic proteins and against other cancers.

Public health relevance
PROJECT NARRATIVE Lung cancer is the leading cause of cancer deaths in the United States. Current treatment options are limited in their scope and efficacy and, thus, the 5-year overall survival remains at less than 30%. Here, a novel self- amplifying ribonucleic acid (saRNA) therapy is proposed which incorporates new modified nucleoside triphosphates and encodes for a potent bispecific T cell engager (BiTE) antibody against lung cancers.